Interoceptive functions of airway brush cells

The primary function of the lung is gas exchange. Immune cells and airway nerves orchestrate interoceptive
defensive responses and adjustments to homeostatic function that preserve airway patency, eliminate noxious
irritants and pathogens from air spaces, clear airway mucus, and optimize the work of breathing. Dysfunction
or dysregulation of these systems directly contribute to the emergence of the physiological and
pathophysiological attributes of respiratory diseases and their associated symptoms. Sensory nerves often
rely on specialized chemosensory signaling mechanisms at their nerve terminals to transduce mucosal
irritation. In the airways, we have described the chemosensory functions of brush cells, their association with
the peripheral terminals of vagal afferent nerves and the reflex effects resulting from their activation. The
central hypothesis of this research proposal is that brush cells orchestrate both immune and reflex responses
in the airways and lungs. We further hypothesize that brush cell dysfunction may contribute to the emergence
of symptoms associated with both acute and chronic diseases of the airways and lungs. Studies proposed
herein aim to: 1) characterize the mechanisms by which brush cells are activated, how they transmit their
activation to adjacent sensory nerves, and the reflexes initiated upon their activation; and 2) determine the role
of ATP and the unique expression of carbonic anhydrase by airway brush cells in transducing airway mucosal
irritation, acidification of airway surface liquid and the accumulation of carbon dioxide in the airway lumen. We
will utilize the innovative techniques that are unique to our laboratories, including transgenic approaches
enabling optical recordings of afferent neurons and brush cells, reflex physiological recordings, single afferent
neuron recording and our molecular approaches to studying both neurons and brush cells. Our focus on brush
cell interactions with afferent nerves is a logical direction for our group, and our plans for hypothesis testing will
be enabled by intriguing recent discoveries summarized below in our Research Strategy. We anticipate that
the results of these proposed studies will reveal novel roles for brush cells and ATP in transducing reflexes
resulting from mucosal irritation in the airways of patients with chronic diseases of the airways and lungs.

Public health relevance
Project narrative: The overall goal of the research outlined in this grant application is to better define the mechanisms by which airway mucosal irritation is transduced into airway defensive reflexes such as cough and bronchospasm. We will focus specifically on the role of the brush cells in the airway epithelium and on the actions of the transmitters and mediators released by brush cells.